COVID-19 vaccine serologic immune response in people with HIV

TITLE: COVID-19 vaccine serologic immune response in people with HIV ABSTRACT MWCCS participants are a high-risk group for severe COVID-19 disease in terms of being HIV-infected, predominately of elderly age, and having numerous underlying comorbidities. Therefore, it is imperative that they receive the new COVID-19 vaccines. In Aim 1 we will study the kinetics and immunoglobulin subclasses of COVID-19 vaccine-induced antibody responses in MWCCS male and female people with HIV (PWH) and matched HIV-uninfected controls (HUC) in a 3-year, longitudinal study against a background of HIV infection and cardiovascular comorbidities. We will perform quantitative assays to study anti-S antibody binding, virus neutralization and the capacity of the antigen-specific IgG1, IgG3 and IgA to mediate complement activation. This will be examined via serological levels of C1q, C3, C3a and C5a. MWCCS core longitudinal visit sera will be analyzed to determine COVID-19 infection post-immunization by detecting anti-N antibodies and to quantify the effect of additional immunizations with COVID vaccines. We will also assay sera for soluble immunological pro- and anti-inflammatory and other biomarkers that relate to HIV-1 infection and cardiovascular disease (CVD) to assess the effect of COVID-19 vaccination on these systemic parameters. In Aim 2 we will analyze the multi-omic immune parameter datasets generated in this project to discover, design, and optimize immune responses against the COVID-19 vaccine in PWH. Our hypothesis is that immunological biomarkers that predict COVID-19 vaccine response outcomes are identified by machine learning approaches on the entire set of features quantified in Aim 1. We will identify innate and adaptive immune parameters from Aim 1 that serve as biomarkers of COVID-19 vaccine outcomes in MWCCS participants using machine learning. This includes assessment of plasma HIV virus load and biomarkers of HIV-related immune activation and inflammation associated with chronic cardiovascular disease parameters already documented in MWCCS participants. This study will be a platform for further, targeted use of core samples for an in-depth investigation of vaccine- mediated immune mechanisms of protection. The participants who seroconvert, defined as V101 anti-N negative followed by anti-N positive sample, will be targeted for in-depth investigation of the immune mechanisms of vaccine-mediated protection, the immunologic responses and virologic characteristics of breakthrough SARS-CoV-2 infections in future investigations.

Public health relevance
NARRATIVE This study will determine if male and female people with HIV (PWH) produce antibodies to COVID-19 vaccines at levels similar to male and female HIV uninfected controls (HUC). We will determine the impact of the amount of HIV (viral load), CD4 count, age and heart problems on these vaccine immune responses. This is important for understanding whether PWH could need, for example, booster doses of COVID-19 vaccines to induce protective immunity.